Mechanism of macrophage efflux system in Mycobacterium tuberculosis pathogenesis

Project Summary
Mycobacterium tuberculosis (M.tb) causes tuberculosis (TB), a serious lung disease that affects over one third
of the global population and results in ~1.5 million deaths every year. TB treatment includes a combination of
three or more anti-TB drugs over a prolonged period (6–9 months). In the last few decades, multidrug-resistant
TB and extensively drug resistant TB strains have emerged due to mismanaged use of anti-TB drugs, (e.g., not
completing the full course of the TB regimen, using the wrong dose or length of administration time, and/or the
use of poor-quality drugs). We propose that shortening the treatment period for clearance of M.tb would assist
to eradicate TB and preventing the development of drug resistance in active and latent TB. We discovered that,
the need for long treatment period is partly due to suppression of the host innate immune response by M.tb,
which involves the efflux of endogenous anti-microbial substances and administered TB drugs from host
macrophages. Specifically, when macrophages are infected with M.tb, expression of the macrophage drug efflux
pump MDR1 increases, resulting in various endogenous and exogenous chemical substances, including TB
drugs, being expelled from macrophages to benefit the survival of the bacteria. Thus, M.tb co-opts these host
pathways. Overall, the mission of my laboratory is to identify molecules in the host that will enable us to create
a novel host-directed therapy for TB. Toward that end, we were the first to discover the link between M.tb
pathogenesis and macrophage MDR1 expression and function during infection. Elevated MDR1 alters the
macrophage innate immune response and subsequent efflux of antimicrobials reduces the effectiveness of
macrophages M.tb killing. We hypothesize that M.tb-dependent upregulation of MDR1 expression in human
macrophages is mediated by heat shock factor protein 1 (HSF1). The aims of the proposed research are to 1)
Define the role of MDR1 in M.tb survival in macrophages; 2) Determine whether HSF1 activation or MDR1
inhibition shortens the sterilization period of M.tb by TB drugs; and 3) Identification of endogenous antimicrobials
produced by macrophages in response to M.tb infection. We will use human monocyte-derived macrophages,
biochemical and genetic techniques, and a mouse model to accomplish our aims. Our basic research discoveries
will jump-start the development of new drugs to treat tuberculosis.

Public health relevance
PUBLIC HEALTH RELEVANCE STATEMENT Tuberculosis (TB), a worldwide infectious disease caused by Mycobacterium tuberculosis (M.tb), has over the last few decades, become resistant to one or more anti-TB drugs, which is a big challenge for TB eradication program. We discovered that M.tb infection enhances the expression and activity of MDR1 in macrophages, which allows the macrophage to transport TB drugs and endogenous anti-microbial out of the cells, thereby promoting M.tb growth. We will investigate whether inhibition of MDR1 expression in mice shortens the TB treatment period and enhance the M.tb killing.